Amyloid-mediated cognitive dysfunction in bacterial pneumonia after TBI

Project Summary/Abstract Bacterial pneumonia leads to harmful clinical manifestations that persist long after
resolution of the primary infection, including cognitive decline; also, patients hospitalized for community-acquired
or nosocomial pneumonia develop cognitive impairment—including the risk of developing Alzheimer’s disease
(AD)-related dementia. Pseudomonas (P.) aeruginosa is a Gram-negative bacterium and common cause of
nosocomial pneumonia in intensive care units (ICU) and traumatic brain injury (TBI) is a risk factor for secondary
bacterial pneumonia, in addition to being a risk factor for cognitive decline. Our preliminary clinical data
demonstrate that TBI patients have increased rates of bacterial pneumonia. In our murine model, mice with P.
aeruginosa pneumonia after TBI have significant learning and memory deficits compared to mice with TBI alone.
Preliminary data indicate that alveolar epithelial cells release amyloid beta (Aβ) after P. aeruginosa infection, Aβ
accumulates in the bronchoalveolar lavage fluid of critically ill patients, and Aβ stimulates expression of tumor
necrosis factor alpha (TNF-α) in alveolar macrophages, suggesting a novel link from pulmonary Aβ to
inflammatory responses. We have published that P. aeruginosa elicits oligomeric Aβ from pulmonary cells,
infection-induced Aβ impairs cognitive function, and that Aβ accumulates in the BALF of pneumonia patients that
correlates with end-organ dysfunction. Finally, Aβ and TNFα activate Neuronal Wiskott–Aldrich syndrome protein
(NWASP) in brain microvascular endothelial cells, resulting in BBB dysfunction and increased permeability. Data
from us and others suggest a novel link between Aβ released from pulmonary epithelial cells and cognitive
dysfunction in mice with bacterial pneumonia after TBI, and Aβ-enhanced inflammatory responses as the
potential mechanism. Therefore, we hypothesize that bacterial pneumonia after TBI induces Aβ expression
and dissemination from alveolar epithelial cells and that Aβ amplifies lung and brain inflammation in an
NWASP-dependent manner that worsens lung barrier and cognitive dysfunction. Our strategies aim to test
that P. aeruginosa-induced Aβ dissemination enhances NWASP-mediated inflammation, leading to exacerbated
cognitive dysfunction in a murine model of bacterial pneumonia after TBI. Aim 1 will determine the molecular
mechanism by which bacterial pneumonia after TBI worsens lung barrier and cognitive dysfunction. Aim 2 will
define the mechanism(s) of BBB breakdown mediated by NWASP and its role in cognitive dysfunction in a murine
model of bacterial pneumonia after TBI. Aim 3 will examine the role of infection-induced amyloids on cognitive
dysfunction in mice and determine the level of amyloids in clinically-relevant, archived, de-identified human
patient samples. There is little data regarding the impact of bacterial pneumonia on cognitive dysfunction after
TBI and this is a significant clinical gap that has yet to be examined; understanding how bacterial pneumonia
after TBI impacts cognitive dysfunction would lead to advances in sepsis research and critical care medicine.

Public health relevance
Project Narrative There is little data regarding the impact of bacterial pneumonia on cognitive dysfunction after traumatic brain injury and this is a significant clinical gap that has yet to be examined. Understanding how bacterial pneumonia after traumatic brain injury impacts cognitive dysfunction, and the associated mechanisms, would lead to a paradigm change in sepsis research and critical care medicine.